Admininstration Core

This Core A (Administration) will serve to provide all management and oversight functions for the overall Drogram. It will also function to facilitate communications amongs project leaders. It will serve as support for manuscript/grant/progress report preparation, and for data posting on the web. Core structure is to have a PI, and Executive Advisory, and Interanl Review committee and a Board of External Reviewers. LAY SUMMARY: This core will provide overall organization for the overall program. This is necessary to meet the experimental goals of the projects, each of which has important public health implications.